Predoctoral Training at the Interface Chemistry and Biology

Support is requested to continue what has proven to be a highly successful program for the training of
predoctoral students at the interface of chemistry and biology. Over the past fifteen years, this CBI
training program has supported 66 graduate students, eight of which have subsequently received NSF,
Keck Foundation, National Defense Science and Engineering Graduate (NDSEG) or American Cancer
Society predoctoral fellowships. In addition, Yale has made a conscious effort to increase its
representation in this interdisciplinary area through new hires and promotions at the junior and senior
levels in the departments of Molecular, Cellular and Developmental Biology (MCDB), Chemistry, and
Molecular Biophysics and Biochemistry (MB&B). Moreover, Yale University’s acquisition of the former
Bayer Pharmaceuticals R&D site in neighboring West Haven allowed the launch a Chemical Biology
Institute, which will ultimately house 9 additional faculty working at the chemistry/biology interface.
Given this expansion of faculty, additional funds are requested to support a total of 12 CBI predoctoral
trainees.
All trainees admitted to the program have at least a Bachelor’s degree in a relevant field and enter via
application to the Chemistry department or to the Yale Biological and Biomedical Sciences (BBS)
program. Regardless of mode of entry all trainees share a common first year experience involving
interdisciplinary course work, laboratory rotations, as well as close supervision and guidance from the
Director of Graduate Students in conjunction with the Executive Committee. At the end of their first year,
trainees chose a thesis advisor from among the 27 CBI trainers and begin intensive research with
additional courses in their second year. Students are supported on this grant in years two and three of
their doctoral training. All students teach for at least one year to aid in their training as teacher-scholars.
Programs for increasing the number of minority trainees and for providing education in ethical issues
related to research represent important parts of this training program.
Special features of the training program include interdepartmental course work, including specially
designed courses for the new trainees, a rigorous interdepartmental rotation schedule during which the
trainee will experience science in three laboratories at Yale, a monthly in-house seminar program for
discussion of recent results, Chemical Biology Fall Retreat and a highly successful annual Chemical
Biology Symposium with a CBI Trainee Poster competition.

Public health relevance
Narrative The Predoctoral Training Program at the Chemistry/Biology interface at Yale University supports the multi-disciplinary graduate education of the next generation of research scientists in chemical biology. Graduates from this program go on to research positions in universities, research institutes, and industry, where they contribute to finding medical solutions to genetic diseases, cancers, and other disorders that afflict humans.